Cellular heterogeneity in mitochondrial calcium dynamics in heart failure

Project Summary/Abstract
Heart failure with preserved ejection fraction (HFpEF) affects nearly 50% of heart failure patients and represents
a significant unmet medical need due to a lack of effective treatments and incomplete understanding of its
molecular mechanisms. Recent studies suggest mitochondrial dysfunction plays a causal role in HFpEF, with
mitochondrial calcium (mCa2+) emerging as a crucial regulator of mitochondrial metabolism and function. While
genetic manipulation of mCa2+ flux in cardiomyocytes has shown promise in heart failure with reduced ejection
fraction (HFrEF), its role in HFpEF remains unexplored. Furthermore, cellular heterogeneity in mCa2+ signaling
and functions in HFpEF, along with the potential therapeutic manipulation of mCa2+ in a heart cell-specific manner,
remain undetermined. This study aims to address these gaps by investigating heart cell-specific mCa2+ signaling
and function in HFpEF. We hypothesize that disrupted cellular heterogeneity in mCa2+ signaling contributes to
HFpEF progression, and therapeutic manipulation of cell type-specific (cardiomyocytes, fibroblasts and
endothelial) mCa2+ flux may offer novel treatment strategies. Our approach involves characterizing heart cell-
specific mCa2+ signaling and functions in HFpEF mouse models (aim1), evaluating the effects of manipulating
mCa2+ flux on HFpEF pathogenesis (aim2), and studying the molecular mechanisms of mitochondrial dysfunction
in HFpEF (aim3). This proposal is significant and innovative, offering insights into heart cell-specific mechanisms
contributing to mitochondrial dysfunction and identifying new therapeutic targets for HFpEF. It shifts the paradigm
by proposing cellular heterogeneity in mCa2+ as a key molecular target for HFpEF. Additionally, it enables the PI
to transition into a new research direction and involves a strong team of investigators with expertise in HFpEF
and cardiovascular studies to ensure project success.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) is a debilitating syndrome that accounts for almost 50% of all hospitalizations for HF, and there are currently no effective treatments for HFpEF due to a limited understanding of its associated molecular mechanisms. It has been shown that mitochondrial dysfunction is central to the initiation and progression of HFpEF, but the molecular mechanisms of mitochondrial dysfunction in HFpEF have yet to be elucidated. This project aims to fill this gap by identifying the mechanisms of mitochondrial dysfunction by studying the role of heart cell-specific mitochondrial calcium signaling and functions in HFpEF, which will significantly improve our understanding of the heart’s mitochondrial homeostasis and could open new avenues for treating HFpEF.